Electrokinetic paper diagnostic platform: 15-minute, quantitative nucleic acidamplification for viral pathogens in whole blood

ABSTRACT COVID-19 is a severe respiratory tract infection caused by the newly discovered, and highly contagious, SARS- CoV-2 virus that emerged in late 2019 in Wuhan, China and has infected over 3 million people globally (> 1M US) and has caused over 215,000 deaths (58,000 US). SARS-CoV-2 RNA is the only sensitive and specific biomarker for diagnosis of an active COVID-19 infection and is diagnosed by reverse-transcription polymerase chain reaction (RT-PCR) in a central virology lab. Several CLIA-waived NAAT systems have been rapidly adapted for testing COVID-19, and have been granted the Emergency Use Authorization (EUA) for use at the point-of-care; however, their use is generally restricted to clinical sites because of the instrument, and/or protocol complexity, and high cost associated with the equipment. Self-administered nasal swabs have been shown to be an effective sample to detect COVID-19, and as a result the FDA is allowing their use as an acceptable specimen for COVID-19 laboratory testing, paving the way for home-based COVID NAT tests. We currently have a NIBIB project focused on the development and validation of a paper microfluidic based POC NAT for quantifying HIV Viral load from whole blood. Here, we propose to leverage this on-going effort to develop a COVID-19 Nucleic Acid Amplification Self Test (COAST) that can be performed at home to detect COVID-19 infections based on SARS-CoV-2 RNA. COAST is fully disposable test will detect as little as 5,000 cp/swab, have a COGS of less than $2.50, and will have sample-to-result within 30 minutes. In this proposal, our primary objectives are (1) optimizing and validating a sensitive and specific Recombinase Polymerase Amplification (RPA) isothermal amplification assay for the N-gene for SARS-CoV-2 RNA with lateral flow readout and (2) developing and evaluating the COAST home-based test with integrated sample preparation, isothermal amplification, lateral flow read-out. RPA is a low-temperature, isothermal amplification chemistry that can specifically detect a target with a wide range of genomic diversity and easily be integrated with LFA read-out. COAST has a novel elution tube, self-regulating positive temperature coefficient heaters, on-paper RPA amplification, and LFA readout. The RPA assay will be validated with de-identified SARS-CoV-2 RNA from COVID-19 patient samples collected by UWs Virology Lab and the COAST cartridge will be evaluated using mock nasal swabs with non-infectious targets. COVID-19 self-testing can drastically increase total testing numbers which can improve state and federal public health officials understanding of disease proliferation, as well as informing policy response (e.g. stay-at-home orders, school closures, etc.) and allocation of emergency response (for example distribution of PPE or ventilators). Self-testing can also reduce new infections by initiating prompt quarantine and public health contact tracing, especially in the case of asymptomatic or mildly symptomatic patients.

Public health relevance
Project Narrative We currently have a NIBIB project focused on the development and validation of a paper microfluidic based POC NAT for quantifying HIV Viral load from whole blood. Here, we propose to leverage this on-going effort to develop a COVID-19 Nucleic Acid Amplification Self Test (COAST) that can be performed at home to detect COVID-19 infections based on SARS-CoV-2 RNA.